Core 3: Mouse GBM models and Imaging Core

Core 3 Abstract
To ensure reproducibility, rigor and harmonization amongst the mouse glioblastoma (GBM) models utilized by
Projects 2, 3 and 4, we have established a mouse GBM model Core that is exclusively utilized for this Program
Project and does not exist within participating Institutions. The Core provides broad centralized access to a
central repository responsible for the maintenance and testing of mouse GBM tumors and professional expertise
related to their stereotactic implantation into mouse brains and the analysis, including imaging of intracranial
GBMs. It also has been providing mouse GBM neoantigen discovery and validation. This would include access
to mouse cell lines and their derivatives critical to the experimental aims. This is more easily accomplished
through the Core and not as easily done through individual (e.g. R01) granting mechanisms or through existing
NIH sponsored service cores at the P01 institutions. This will be accomplished by pursuing two specific aims:
generate and maintain a repository of mouse GBM cells, engineer GBM cells that express transgenes of interest,
and identify and validate mouse GBM neoantigens (Aim 1) and provide the technical expertise and performance
for the stereotactic implantation of mouse GBMs in brains and for their serial imaging (Aim 2). The provision of
these services for 3 of the 4 Projects will reduce expense, will reduce technical and sample bias and will ensure
that the 3 Projects will employ the same well characterized mouse GBM cells that are implanted and imaged by
expert technical personnel.

Public health relevance
Narrative Core 3 will provide services to Projects 2, 3 and 4 by providing well characterized mouse GBM cells and by performing the intracranial implantation procedures to establish GBMs in mouse brains. Monitoring of GBM growth will be performed utilizing small animal MRIs and bioluminescence imaging.